Lifecourse Predictors and Mechanisms of Early Clinical ADRD among Black and White Adults in their Sixties

ABSTRACT
The physiologic and neuropathologic processes in Alzheimer disease (AD) and Alzheimer disease related
disorders (ADRD) are insidious and take decades to develop. Furthermore, the likelihood of developing
AD/ADRD is influenced by the interplay of genetics and risk/resilience factors, especially cardiovascular
disease (CVD) risk factors and social determinants of health (SDOH), that operate over the life course. Given
that the new AD disease modifying therapies are believed to be most effective in the early stages, as well as
the tremendous burden that AD/ADRD places on patients, caregivers, and society, it is imperative to identify
the earliest manifestations of these diseases in order to offer better prevention/treatment, particularly in more
diverse populations. The transition from midlife to early late-life offers an exciting and under investigated time
period for early clinical AD/ADRD development and how this may differ according to race and sex. We propose
to conduct a Year 40 (when participants have a mean age of 65) cognitive assessment and AD/ADRD
adjudication among the ongoing Coronary Artery Risk Development in Young Adults (CARDIA) study in order
to investigate this early late-life transition to clinical AD/ADRD and to determine underlying mechanistic
pathways that may highlight prevention opportunities. CARDIA is uniquely positioned to address this line of
investigation as it has repeated cognitive and brain MRI measures over the midlife period and is comprised of
roughly equal numbers of Black and White participants who have been followed since their 20’s. We
hypothesize that the early late-life period (when participants are in their 60s) is a critical window of opportunity
to identify the transition to early clinical AD/ADRD and determine how this is influenced by early
neurodegenerative (assessed by MRI, genetics, blood AD biomarkers and other factors) as well as vascular
pathways (assessed by CVD, genetics, MRI and other factors). In turn, because CARDIA is balanced by race
and sex, we will be in an excellent position to investigate disparities in the midlife to late-life transition to early
AD/ADRD and whether mechanistic drivers differ by sex and race. We will also identify the life course
predictors of this early AD/ADRD with a particular focus on comprehensive measures of SDOH and determine
how SDOH also may influence proposed mechanistic pathways and their changes over time. Finally, as part of
an exploratory aim, we will develop a prognostic model for AD/ADRD in the 60s incorporating life course risk
factors, MRI measures, AD biomarkers, genetics and other data elements. This model will be essential for
future risk prognostication as AD/ADRD drug development and prevention strategies advance and there is
need to identify people as early as midlife in order to target primary prevention. Findings from this innovative
study will provide highly relevant results to the field of AD/ADRD by providing critical information on the midlife
to early late-life transition to AD/ADRD, the mechanistic pathways behind these changes, SDOH influences,
and the underpinnings of health disparities for AD/ADRD.

Public health relevance
PROJECT NARRATIVE The transition from midlife to early late-life offers an exciting and under investigated time period to study early clinical Alzheimer disease (AD) and Alzheimer disease related dementias (ADRD) development and how this may differ according to race and sex. We propose to conduct a Year 40 (participant mean age of 65) cognitive assessment and AD/ADRD adjudication with AD biomarker assays among the ongoing biracial Coronary Artery Risk Development in Young Adults (CARDIA) study in order to investigate this crucial early-late life transition to AD/ADRD and to determine underlying mechanistic pathways by race and sex. In this way, the proposal has great significance as it will provide critical information on the earliest transition to AD/ADRD, examine pressing health disparities, and identify targeted ways to possibly delay or prevent AD/ADRD.